Equipment Supplement - NOT-GM-24-021 (PI: J. Stumpff)

PROJECT SUMMARY
The accurate segregation of chromosomes by the microtubule-based mitotic spindle during mitosis is
essential for the preservation of genomic integrity. Errors in mitotic spindle function lead to chromosome
missegregation, aneuploidy, and the formation of micronuclei, all hallmarks of tumor cells. Molecular motors
of the kinesin superfamily play important mechanical roles in controlling the movement and organization of
chromosomes within the spindle, including the generation of forces on chromosome arms, regulation of
spindle microtubule length changes, and the crosslinking and sliding of microtubule overlaps. Many of the
molecular mechanisms underlying kinesin function in cells remain poorly understood. This proposal seeks to
fill knowledge gaps in our understanding of how kinesins function at the molecular level to ensure the accuracy
of mitotic chromosome segregation. How do the structures of kinesins tune their activities for particular roles
in cells? How are these activities spatially and temporally regulated? What is the molecular basis for cell type
specific requirements of kinesin function? What are the short and long-term consequences of abnormal
kinesin activities? An interdisciplinary approach combining biophysics, quantitative live cell imaging, and
structural mutagenesis will be employed to address these outstanding questions across biological scales from
the single molecule to single cell, to tissue and whole organism levels. This administrative supplement
application seeks funds to purchase a spinning disk microscope system essential for successfully addressing
these questions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because proper control of chromosome segregation is necessary to prevent aneuploidy and genomic instability, which contribute to the development and progression of tumors and trisomy syndromes. Furthermore, determining the mechanisms and regulation of kinesin motor proteins is directly related to understanding how alterations in the functions of these proteins disrupt development and contribute to congenital disorders and cancer.